UAB Center for Precision Animal Modeling (CPAM)

ABSTRACT (OVERALL SECTION)
The identification of genetic variants associated with human diseases is accelerating, thanks to advances in
technology and reduced costs of next-generation sequencing. Distinguishing between pathogenic and benign
variants poses a significant challenge, necessitating robust informatics tools complemented with experimental
validation. These tools must analyze extensive amounts of data and present it in a comprehensive and
accessible format for expert evaluation and prioritization of the variants based on likely clinical significance.
These tools must help select optimal model systems in which to engineer the variant to mimic human disease,
to study disease mechanisms, identify and test therapeutics, and to develop diagnostic tools and clinical care
strategies. To tackle this complex set of issues, we established the Center for Precision Animal Modeling
(CPAM1.0) in 2020. CPAM’s multidisciplinary team encompasses expertise in clinical care, disease diagnostics,
genetics, computational and data sciences, artificial intelligence and machine learning, genome engineering,
disease modeling, and therapeutic screening. This network of expertise forms a well-integrated and efficient
CPAM analysis platform through which community-based nominations undergo systematic evaluation using
established criteria, ensuring that selected variants represent both scientific merit and potential patient benefit.
CPAM’s Preclinical/Co-clinical Section (PCS) serves as the liaison for incoming nominations and manages
comprehensive patient clinical data collection, ensuring secure integration of medical records, genomic
information, and treatment histories along with robust patient protection policies. The PCS received 169
submissions over the past four years, highlighting the demand. Each nominated variant undergoes thorough
analysis by our Bioinformatics Section (BIS), with reports presented to the Steering Committee (SC) for
evaluation, selection and prioritization of variants for further modeling. For projects that CPAM accepts for
disease modeling, the Coordination Section (CS) initiates collaborations and the BIS employs AI approaches to
identify therapeutic strategies. The Disease Modeling Unit (DMU) develops patient variant human cell and animal
models across multiple species. These models are analyzed in parallel with clinical investigation enabling direct
comparisons to help ensure that CPAM animal models effectively predict treatment outcomes and accelerate
therapeutic development. Concurrently, the Resource and Service Section (RSS) and the BIS develop functional
assays to assess variant pathogenicity and test prioritized drugs. After establishing the animal model, the RSS
conducts quality control, cryopreserves the line, and distributes it to collaborators and repositories. The DMU
evaluates phenotypes, and interfaces with the BIS, PCS and a Phenotype Validation and Clinical Curation
Committee to assess human disease relevance. Finally, the BIS compiles all data into a final Patient Variant
Report and the PCS returns results to the nominator. Ultimately, CPAM has a pivotal role in driving the translation
of genomic discoveries into tailored therapies that can significantly improve patient outcomes.

Public health relevance
PROJECT NARRATIVE (OVERALL SECTION) Undiagnosed disease programs and other large scale human genome projects struggle with the large number of genomic variants that lack sufficient functional evidence to assign disease causation, making diagnosis and clinical action challenging. The Center for Precision Animal Modeling (CPAM) at UAB has established an efficient well-integrated clinical, informatic, animal modeling, and therapeutic testing pipeline to assess disease causation of community-nominated patient variants. The CPAM pipeline is advancing our understanding of novel disease mechanisms, establishing new diagnostic and treatment capabilities, and is contributing to the development of novel strategies to improve patient care.